Supplement to Effectiveness of Digital Versus In-Person Diabetes Prevention Programs

PROJECT SUMMARY
We seek a budget supplement to bolster the completion of our ongoing randomized controlled trial (RCT),
registered as NCT05056376 on ClinicalTrials.gov, funded by the National Institute of Diabetes and Digestive
and Kidney Diseases grant R01DK125780. The RCT studies the comparison between a fully automated digital
diabetes prevention program (dDPP), Sweetch Health Ltd., which leverages AI technology for adaptive lifestyle
coaching, and the standard of care human coach-based diabetes prevention programs (hDPPs). Despite
prediabetes posing significant risks for developing type 2 diabetes, millions of U.S. adults lack adequate
lifestyle counseling to mitigate this risk. Mobile health (mHealth) technologies, like Sweetch, provide a scalable
solution to this widespread issue.
This project’s objective is to determine whether the AI-driven dDPP is as effective as traditional hDPPs in
improving health outcomes for prediabetic adults. This population is particularly susceptible and stands to
benefit greatly from interventions.
Our RCT addresses an evidence gap in chronic disease prevention and health behavior change, underpinned
by promising short-term results from our preliminary trial. The study, set to complete randomization of final
study participants by the end of 2023, will recruit 368 prediabetic adults aged 18-75 who are overweight/obese.
Participants are split evenly into two arms: Arm 1 (N=184) receives the fully automated Sweetch digital health
kit (dDPP arm) while Arm 2 (N=184) engages in a local CDC-recognized hDPP through in-person or distance
learning.
Both arms undergo rigorous physical activity measurements using actigraphy at baseline and 1-month intervals
throughout the study. We hypothesize that the dDPP will be non-inferior to the hDPP for achieving the CDC’s
type 2 diabetes risk reduction endpoint at 12 months. We also anticipate that the dDPP will garner higher
engagement and acceptability due to its flexibility and convenience.
The supplement is required for unexpected costs related to actigraphy, increased Medicare reimbursement for
the hDPP, and travel expenses for home study visits, prompted by the COVID-19 pandemic. Completing this
study will clarify the potential of fully automated digital interventions using AI for delivering effective, scalable,
sustainable, and cost-effective health-promoting behavioral change interventions. Its success can profoundly
impact scalability in diabetes prevention.

Public health relevance
PROJECT NARRATIVE We request a budget supplement to support the successful completion of our ongoing randomized controlled trial (RCT) that compares an AI-driven digital diabetes prevention program (dDPP), Sweetch Health Ltd., to traditional human coach-based diabetes prevention programs (hDPPs). This RCT, targeting prediabetic adults, aims to address a critical evidence gap in chronic disease prevention and health behavior change, backed by promising short-term results from our preliminary studies. The supplement will cover unexpected costs related to actigraphy, increased Medicare reimbursement for the hDPP, and travel expenses for home study visits prompted by the COVID-19 pandemic, ultimately advancing scalable and sustainable chronic disease prevention strategies.